Comprehensive Analysis, Surveillance, and Statistics Initiative for Diabetes in the Young (CASSIDY)

PROJECT SUMMARY
People with diabetes are at high risk of developing a range of diverse microvascular, macrovascular and
neuropathic complications that are associated with high morbidity and erode their quality of life. Diabetes is
expected to take an increasingly large financial toll in in the United States (U.S.) in the future, particularly among
working age adults. Ongoing, timely and efficient surveillance of incidents and prevalent type 1 and type 2
diabetes diagnosed among youth and young adults is essential to identify health disparities and inform health
care systems and the public health community on prioritizing strategies to prevent diabetes and its complications.
The Colorado CASSIDY surveillance team is ideally situated to generate timely and accurate estimates of the
prevalence and incidence of diabetes in youth and young adults from a near complete representation of health
systems throughout our state, established in SEARCH, expanded in the Assessing the Burden of Diabetes by
Type in Children, Adolescents, and Young Adults (DiCAYA) and further enriched for CASSIDY to allow our state
to function as a health system site with a demographically and geographically representative population under
surveillance. Our longstanding leadership in diabetes surveillance and research, institutional and statewide
healthcare system partner commitment and the opportunity to directly validate the coverage and
representativeness of statewide, deduplicated utilization-based denominators make us a valuable partner for the
CASSIDY project. Our integrated surveillance approach was honed during our participation in DiCAYA, utilizing
a combination of algorithms, incremental record linkage and chart review to identify individuals with diabetes,
distinguish diabetes type and estimate date of diagnosis. Our specific aims are: Aim 1: SURVEILLANCE
(Prevalence)- To ascertain cases of prevalent diabetes among individuals aged <45, by age, sex, race/ethnicity,
geography and diabetes type; Aim 2: SURVEILLANCE (Incidence)- To ascertain newly diagnosed diabetes
cases in young adults age <45 years at diagnosis, by age, sex, race/ethnicity, geography and diabetes type;
Aim 3: EVALUATE PUBLIC HEALTH SURVEILLANCE METHODS - To evaluate the strengths and challenges
of our integrated surveillance approach to determine the burden and risk of diabetes among youth and young
adults by assessing validity, completeness and representativeness of case ascertainment methods and the
potential utility of utilization-based denominators.

Public health relevance
PROJECT NARRATIVE Ongoing, timely and efficient surveillance of type 1 and type 2 diabetes among youth and young adults is essential to identify disparities and inform health systems and the public health community on priorities for prevention and treatment. The Colorado CASSIDY Team has developed a nearly comprehensive surveillance network of health systems across our state, that represents the economic, geographic and demographic diversity of our state's census. Investigators at the University of Colorado Anschutz Medical Center bring decades of expertise in diabetes surveillance and registries, and our statewide healthcare institutions are deeply committed to working together to further the science of diabetes surveillance in youth and young adults. Our proposed approach is flexible and sustainable over time by utilizing semi-automated, validated algorithms to ascertain prevalent and incident diabetes. Our ability to provide deduplicated utilization-based denominators and evaluate their coverage across our state will advance approaches for surveillance using electronic health records.